The role of TGF-β signaling in cell-cell interactions in the pathogenesis of lymphangioleiomyomatosis

RESEARCH SUMMARY
Pulmonary lymphangioleiomyomatosis (LAM) is a rare, female-predominant lung disease that is caused by
inactivating mutations in the tuberous sclerosis complex (TSC1/2) tumor suppressor genes and consequent
downstream hyperactivation of the mammalian target of rapamycin (mTOR) pathway. TSC1/2 mutations in LAM-
initiating cells are central to disease pathogenesis, in collaboration with non-mutated native lung cells, including
fibroblasts, endothelial, and alveolar epithelial cells. Rapamycin, the only FDA-approved treatment for LAM is
cytostatic rather than cytotoxic and is associated with acquired resistance and adverse effects resulting its
discontinuation. My proposal addresses a critical need to identify new therapeutic targets in LAM, and this will
require the development of tissue-level in vitro LAM models that represent the cellular complexity of the disease.
Lung cells within and surrounding clusters of LAM cells exhibit notable changes, particularly in fibroblasts, where
markers of activation are significantly upregulated. Additionally, in alveolar epithelial cells the number of KRT8+
transitional-state cells is abnormally high. Using TSC2-/- renal angiomyolipoma cells (TSC2-/-AML) as a surrogate
for LAM cells, my preliminary data demonstrates that secreted levels of several growth factors, including TGF-
β1 and TGF-β2 are upregulated. These growth factors are known to promote fibroblast activation and influence
alveolar differentiation, however they have yet to be evaluated in the context of LAM pathogenesis. The objective
of my study is, therefore, to elucidate the role of TGF-β signaling in LAM pathogenesis. My central hypothesis is
that TGF-β acts as a critical regulator of intercellular signaling, and its upregulation drives LAM progression by
promoting fibroblast activation and alveolar simplification. To test this hypothesis, in Aim 1, I will determine the
extent to which TSC2 inactivation and subsequent mTOR hyperactivation, using TSC2-/-AML cells, influence
intra- and intercellular TGF-β signaling. I will use 2D and 3D co-culture models seeded with TSC2-/- or TSC2+
AML cells and non-diseased fibroblasts to determine how TSC2 inactivation affects TGF-β signaling activation
and fibroblast phenotypes. Quantitative methods including live cell imaging, protein and RNA quantification will
be used to measure changes in TGF-β signaling and fibroblast activation. Functional assays, such as wound
healing assays and electrical cell impedance sensing (ECIS), will quantify the impact of TSC2-/- cells on fibroblast
function. In Aim 2, I will develop a trans-well model of co-cultured TSC2-/- cells and primary AT2 cells and a LAM-
on-chip model, to recapitulate interactions among TSC2-/- cells, fibroblasts, and AT2 cells; and use this model in
conjunction with genetic and pharmacologic manipulation of mTOR and TGF-β signaling to both determine the
extent to which TSC2-dependent TGF-β signaling influences differentiation of the alveolar epithelium and identify
mechanisms by which LAM causes alveolar dysfunction. The proposed study is expected to provide mechanistic
insights into the role of TGF-β signaling in LAM and its impact on various cell types within the disease
microenvironment, identifying new therapeutic targets.

Public health relevance
PROJECT NARRATIVE Pulmonary lymphangioleiomyomatosis (LAM) is a rare cystic lung disease that involves multiple intercellular signaling pathways and leads to pathological fibroblast activation and alveolar simplification. Signaling by the TGF-β pathway has been implicated in these outcomes, but how it contributes to LAM remains unclear, in part due to a lack of appropriate culture models in which to study the relevant cell-cell interactions. I propose to use unique 3D culture models designed to sustain the relevant transient cell types to identify the role of intercellular TGF-β signaling in LAM pathogenesis.